Revitalizing Tennessee's Core Environmental Health Programs: Food Safety and Wate

DESCRIPTION (provided by applicant): Abstract-Tennessee EHS-Net Application 2010 Foodborne and waterborne pathogens cause substantial burden of illness. The Tennessee Department of Health (TDH) considers involvement in EHS-Net vital to promoting safe practices, educating environmentalists and epidemiologists in outbreak investigation, preventing illness, adding to the body of generalizable knowledge about food/water safety and environmental contamination, and demonstrating to the public the value of food and water safety measures. This application will demonstrate our EHS-Net objectives, our history of EHS-Net accomplishments, and our future EHS- Net plans. We will continue the interagency approach in EHS-Net Food Program by supporting two full- time environmentalists in two of the state's large, comprehensive food safety programs. These environmental specialists and the EHS-Net PI will actively contribute to all aspects of multi-state food safety projects and participate in steering committee and working group calls. New projects will include the following: 1) complete an introductory survey to fully characterize the 232 grocery stores in Nashville, Davidson County;2) implement food flow and contributing factor evaluation in restaurant- associated foodborne outbreaks statewide;3) evaluate the effectiveness of an ongoing remedial food safety training on the long-term performance low-scoring restaurants;4) integrate use of a standard foodborne illness complaint form into the state's environmental health information system;5) as follow- on to a previous project, analyze the previous eight years of statewide restaurant inspection data. Continued participation in multi-state EHS-Net studies will also remain a high priority. Tennessee's involvement in the EHS-Net Water Safety Program since 2005 has led to numerous improvements in waterborne disease prevention, detection, and investigation. Numerous projects and investigations have enabled interaction with local, state, and federal stakeholders. During 2008-2009, we conducted multi-agency outbreak investigations, including a household sewage outlet cross connected to the water main supplying a small community, a source water contamination in a small community water system, and a municipal waste water treatment bypass to surface streams. With EHS-Net support, the state public health laboratory gained capacity to isolate and speciate Cryptosporidium from stool and environmental field samples. We will continue multistate EHS-Net projects and begin two new locally designed projects identified as priorities for additional study and data collection: 1) to identify and understand species-specific factors associated with the increased reports of cryptosporidiosis in east Tennessee, and 2) collect detailed location and use information for private water wells and onsite sewage disposal systems in Tennessee. PUBLIC HEALTH RELEVANCE: EHS-Net Food Safety-Tennessee 1) Introduction to application Each year in the U.S., foodborne pathogens such as Salmonella, Campylobacter, and E. coli O157:H7 cause millions of illnesses, sometimes with severe outcomes. In recent years, as people eat more food served by restaurants and as ready-to-eat food products are distributed over wider areas, illness and outbreaks caused by contamination of food have gained wider publicity, yet the public does not always consider food safety regulation and food recalls as effective tools in preventing illness. We at the Tennessee Department of Health (TDH) are concerned with preventing foodborne outbreaks by promoting safe food handling practices and by working on local and national levels to understand how these outbreaks occur. We consider involvement in projects such as Environmental Health Specialist (EHS)-Net and FoodNet vital to our work of promoting safe food handling practices, educating environmentalists and epidemiologists in outbreak investigation, preventing illness, and adding to the body of generalizable knowledge about food safety and environmental contamination. This application for funding through Centers for Disease Control (CDC) will demonstrate our objectives in working with EHS-Net, our

Public health relevance
EHS-Net Food Safety-Tennessee 1) Introduction to application Each year in the U.S., foodborne pathogens such as Salmonella, Campylobacter, and E. coli O157:H7 cause millions of illnesses, sometimes with severe outcomes. In recent years, as people eat more food served by restaurants and as ready-to-eat food products are distributed over wider areas, illness and outbreaks caused by contamination of food have gained wider publicity, yet the public does not always consider food safety regulation and food recalls as effective tools in preventing illness. We at the Tennessee Department of Health (TDH) are concerned with preventing foodborne outbreaks by promoting safe food handling practices and by working on local and national levels to understand how these outbreaks occur. We consider involvement in projects such as Environmental Health Specialist (EHS)-Net and FoodNet vital to our work of promoting safe food handling practices, educating environmentalists and epidemiologists in outbreak investigation, preventing illness, and adding to the body of generalizable knowledge about food safety and environmental contamination. This application for funding through Centers for Disease Control (CDC) will demonstrate our objectives in working with EHS-Net, our extensive history of accomplishments within EHS-Net, and our plans for future work. 2) Specific aims The goal of the EHS-Net Food Program in Tennessee is to enhance our understanding of foodborne diseases, their causes and exposure routes, and ways that illness can be prevented through education, increased understanding, and stronger collaborations between the Tennessee Department of Health Communicable and Environmental Disease Service, TDH General Environmental Health food safety staff, Tennessee Department of Agriculture retail food programs, the Metro Public Health Department of Nashville and Davidson County (Metro), and regional and local health agencies, epidemiologists, and laboratorians. For this research opportunity, we seek EHS-Net funds for our continued involvement in numerous collaborative projects with other EHS-Net sites and participating agencies, locally designed interventional and research projects which we have identified as priorities, and new projects that will emerge from the team assembled as part of the 2010-2015 grant cycle. The aims for Tennessee's involvement in EHS-Net in 2010 are as follows: • Understand environmental antecedents to foodborne disease outbreaks • Establish the value of routine restaurant inspections and food safety education to food safety and identify areas of foodborne disease prevention that need improvement in Tennessee and nationwide (performance indicators) • Promote enhanced expertise in regulation and investigation in grocery and market settings, recognizing variations in regulation compared to restaurants • Implement statewide use of an outbreak-specific restaurant inspection tool and collect information that will allow use of the performance measures promoted by the Council to Improve Foodborne Outbreak Response (CIFOR) in evaluating Tennessee's response to foodborne foodservice- associated outbreaks 3) Background and significance Foodborne disease outbreak investigations and reporting are a high priority for the Tennessee Department of Health. EHS-Net-funded activities related to outbreak prevention, identification, investigation, and reporting enhance TDH's response and further mitigate and prevent foodborne diseases in Tennessee. Foodborne outbreak investigations lead to recall of contaminated food products and identification of processing and preparation interventions to reduce enteric pathogen contamination of foods. TDH has been a participant in the Environmental Health Specialist Network (EHS-Net) since its inception in 2000. EHS-Net involvement has led to substantial improvements in the infrastructure of the General Environmental Health (GEH) and Communicable and Environmental Disease Services (CEDS) sections of the Tennessee Department of Health. Surveillance for illness and other public health threats has markedly improved, as has our capacity to respond to and investigate outbreaks and other public health emergencies. While the epidemiology and environmental staff in the Tennessee Department of Health have good working relationships, past resource limitations have prevented any systematic examination of environmental antecedents to foodborne, foodservice-associated outbreaks or evaluation of the effectiveness of intervention strategies at the local or state levels. Similarly, foodservice regulatory agencies within metropolitan health departments that are independent of regulation by GEH have traditionally had limited ongoing interaction with academic or state epidemiology colleagues except in acute outbreak settings. Foodservice establishments in Tennessee are regularly inspected by sanitarians and environmentalists, yet the public health benefits of these inspections are not well documented. Additionally, these routine inspection procedures are not focused or designed to be specifically addressed in outbreak investigations. Local, state, and national policy makers sometimes lack scientific evidence to support decisions regarding the regulation of the foodservice industry. This scientific evidence also informs current recommendations and facilitates meaningful educational efforts. Education is important to promoting food safety among consumers, retailers, restaurant owners, managers, and employees. Education of low-scoring restaurants' managers and employees has been demonstrated to improve subsequent scores, yet the duration of this effect has not been well documented. 4) Preliminary studies/progress report The priority status of food safety and foodborne outbreak investigation in Tennessee has been enhanced by our involvement in EHS-Net during the previous 10 years. Previous funding by the Environmental Health Specialist Network Cooperative Agreement has allowed us to improve Tennessee's response to foodborne outbreaks through the work of two full-time environmental specialists placed in the statewide food safety agency and the large metropolitan program in Nashville and Davidson County. A variety of educational, interventional, and research projects have been accomplished. This programming in Tennessee is enhanced by the effort of several key personnel and their involvement in local, state, and national food safety promotional efforts. These key personnel are included in Appendix 1. Involvement in food safety projects such as FoodNet and EHS-Net necessitates a staff that also includes six full-time epidemiologists, a doctoral level program manager, and three public health nurses, in addition to the two environmentalists already mentioned. The Tennessee EHS-Net program has effectively leveraged a number of other state and federal resources to augment the EHS-Net program in the state. Emerging Infections Program and Epidemiology and Laboratory Capacity Cooperative Agreement funds support key departmental personnel and several epidemiology and laboratory staff that contribute substantively to EHS-Net projects. Administrative and grant-management support is provided to EHS-Net by a coordinator in CEDS with substantial experience with other cooperative agreements. Health Department staff provide computer equipment and support to the EHS-Net specialists. CEDS and GEH staff are enthusiastic about EHS-Net and dedicated to continuing to ensure that local, state and other federal resources are available to actively support the EHS-Net program. Tennessee's capacity to fully participate in EHS-Net is facilitated not only by in-kind support from the state and metro health departments and the paid EHS-Net staff but also by the existing intellectual capacity at TDH and Metro. CEDS personnel and EHS-Net staff have presented foodborne disease information at numerous national conferences and in peer-reviewed publications recently. Selected 2008-2009 publications and presentations are included in Appendix 2. With the critical support of EHS-Net, foodborne disease outbreak detection, response, and reporting have improved dramatically in Tennessee since 2000 (See Figure). Laboratory capacity leading to increased outbreak detection has been important at state and regional/county levels. Tennessee continues to promote and support implementation of analytic epidemiologic studies. 35 32 33 30 24 25 25 21 19 20 17 17 15 16 15 10 10 5 0001 0 2 0 # outbreaks 12909034567890123456789 Year Reported foodborne disease outbreaks in Tennessee, 1993-2009 Tennessee's outstanding performance in investigating and reporting outbreaks is possible partly because of enhanced education and emphasis stemming from involvement in collaborative projects such as EHS-Net. For 2009, the proportion of outbreaks with etiology determined was 94% (target: >90%), and source/vehicle was identified in 88% of outbreaks (target: >50%). In 2008, the latest year for which Electronic Foodborne Outbreak Reporting System (EFORS) data entry timing results are available, Tennessee entered 80% of foodborne outbreaks into EFORS within 60 days. Epi-Ready and Epi-Ready Train-the-Trainer courses were completed by key departmental leadership, including Dr. John Dunn, Dr. Robyn Atkinson, assistant director of TDH Laboratory Services, and Ryan Mason, TDH EHS-Net specialist, in August 2008. Having this EHS-Net specialist on staff has given the environmental health division sufficient capacity to allow participation in this training and subsequent planning of Epi-Ready Training sessions within Tennessee. Additional and ongoing training to use outbreak specific inspection techniques and a cooperative, analytic epidemiology approach by field staff is critical to identifying food vehicles. The Tennessee FoodNet program, with support from EHS-Net, has participated in the National Antimicrobial Resistance Monitoring System (NARMS) retail meat study since its inception and remained active during the current budget period. During the previous grant cycles, EHS-Net staff included two full-time environmentalists, one in the state's food safety program and one in the Nashville/Davidson County Health Department. Placement in these agencies provided access to foodservice establishments throughout the state. Vital channels of communication and collaboration were strengthened by actively working together on EHS-Net projects, and food safety was improved. These environmental specialists and the EHS-Net Principal Investigator (PI) actively contributed to the development, implementation, data collection, analysis, and presentation of multi- state food safety projects and were active participants during all steering committee and working group calls. Tennessee EHS-Net staff have contributed substantially to the design of three multistate and five local studies, have contributed participant interviews in all EHS-Net multistate studies, frequently exceeding the required sample size by 100%, and have led analysis efforts for one study. We have participated in dissemination of multiple studies' results through e20 publications and e13 scientific presentations by EHS-Net staff (see list in Appendix 2). This EHS-Net teamwork has contributed to the effectiveness and stability of EHS-Net as a meaningful national project and has encouraged discussion and awareness of EHS-Net in the public health community. Tennessee EHS-Net staff have also taken leadership roles with other food safety projects and collaborative organizations such as Council to Improve Foodborne Outbreak Response, the Tennessee Food Safety Task Force, and the Southeastern Center for Emerging Biologic Threats. These interactions with food safety professionals within and outside of EHS-Net have led to the generation of new ideas and approaches to restaurant inspections and stakeholder interaction, which were distributed to environmentalists and epidemiologists statewide. In 2009, CIFOR published "Guidelines for Foodborne Disease Outbreak Response," with Tennessee leadership. This document has also guided the current revision of the TN Foodborne Outbreak Manual. With substantial EHS- Net staff support, TDH formed a Foodborne Outbreak Training Team to conduct a TN-specific version of the National Environmental Health Association (NEHA) sponsored National Epi-Ready Foodborne Illness Response Strategies course in February 2010. Locally the impact of EHS-Net is felt in improved investigation of restaurant-associated foodborne outbreaks. Investigation of e47 Tennessee outbreaks by EHS-Net staff has been completed using the EHS-Net-designed outbreak investigation tool. This tool emphasizes certain aspects of restaurant work most likely to contribute to foodborne illness and excludes certain regulatory inspection aspects not likely to aid in outbreak investigation. These outbreaks have been more effectively investigated because of this tool, and a high proportion of Tennessee investigations have identified both etiology and vehicle and have led to identification and mitigation of contributing factors. Local training expertise and capacity has been facilitated by EHS-Net. Specifically, a program to upgrade knowledge and food safety practices at low-scoring restaurants was designed and launched by the EHS-Net specialist in Nashville/Davidson County Health Department. The training includes classroom lectures for restaurant employees and management, as well as on-site demonstrations and identification of poor practices. Since its inception, 342 restaurants and 609 foodworkers have participated. Participation in this program has led to dramatically improved scores in follow-up inspections. The following is a brief history and current status of projects for which Tennessee EHS-Net staff have provided leadership or participated in recruitment and survey activities: Allergens study: A recent research study analyzed data on food-allergic fatalities associated with food eaten in restaurants (Weiss & Munoz-Furlong, 2008). The results indicate that the fatal reactions were sometimes the result of action or inaction on the part of the food-allergic individual, restaurant personnel, or both. Few studies have examined restaurants' policies and practices concerning food allergies, or the knowledge and attitudes of restaurant staff concerning food allergies. The purpose of this study started, in February 2009, is to gain a better understanding of these issues. With co-leadership by the Tennessee EHS-Net specialist, two draft questionnaires have been developed and pilot tested. Leafy green handling study: Multiple foodborne illness outbreaks have been associated with raw leafy greens served in restaurants, but a literature review revealed few studies on leafy green storage and preparation in restaurants. This study collected descriptive data on leafy green storage and preparation policies and practices in restaurants. Tennessee EHS-Net was involved in the design and pilot testing of the instrument and collected and entered data into the EHS information system for the target 50 establishments. Outbreak/non-outbreak restaurant inspection study: Tennessee EHS-Net representatives were instrumental in developing the first version of this study instrument and have actively participated in the refining of the study and subsequent revisions of the survey tool. Since study inception, Tennessee has collected data on >90% of restaurant-associated outbreaks in the surveillance area and is actively participating in the newest cycle of the study. One major finding of this study was that restaurants with a certified kitchen manager were less likely to be implicated in a foodborne outbreak. To further characterize this finding, another study of kitchen manager certification was designed and is in process of Institutional Review Board (IRB) approval. Ill food handler study: Tennessee EHS-Net staff has been involved in this study's development, pilot testing, and analysis. Data in Tennessee were collected from 52 establishments (of a required 50). Tennessee provides leadership to the data analysis workgroup and is working toward producing a manuscript. Findings from this study will lead to improved understanding of motivations and barriers to staying home when ill and could help public health agencies design more focused intervention strategies. An abstract submitted by Tennessee has been accepted for presentation at the 2010 USDA Food Safety Education Conference. Chicken handling study: The EHS-Net specialist in Nashville participated actively in the development of the chicken-handling survey tool. This study investigates cross-contamination and heat processing associated with chicken products and will involve both a manager interview and observational components. Tennessee EHS-Net completed 50 surveys. Cooling study: The cooling study led by Tennessee EHS-Net specialist Danny Ripley aimed to better understand potentially hazardous food cooling procedures among restaurants within the EHS- Net capture areas. The survey was designed, pilot tested, and data is currently being collected in 50 establishments in each site, according to the study protocol, with continued leadership from Tennessee. Tomato handling study: Tennessee EHS-Net staff participated in development and subsequent data collection for the tomato handling study. Recent large outbreaks have highlighted the importance of better understanding the range of current practices, identifying potential areas for modification determining models of best practice, and assessing system modifications. Tennessee collected data from 100 participating establishments for this study (200% of the site quota). The data have been analyzed and a publication has been accepted for publication in the Journal of Food Protection. Tennessee EHS-Net specialist Ryan Mason was a co-author of this publication. Retail food study: A major Tennessee EHS-Net collaborative effort has been the National Antimicrobial Resistance Monitoring System (NARMS) Retail Food Study. In this study, EHS-Net specialist Ryan Mason purchased uncooked meat from retail grocery stores each month in Metro Nashville/Davidson County and submitted those purchases to the Tennessee Department of Health State Laboratory in Nashville where samples were tested for contamination, including Campylobacter, Salmonella, Enterococcus, and E. coli using standardized methods and procedures. During the last two years, Tennessee has also expanded the geographic distribution of submitted specimens to include the Metro Knoxville/Knox County area. Tennessee EHS-Net staff participated in a C. dificile pilot project associated with the FoodNet/NARMS retail food study. The objective was to perform a rapid assessment of whether C. difficile is commonly found on meat sold in the United States, and, if so, whether isolates are related to, or share important virulence factors with, human isolates. The Tennessee EHS-Net site is one of two sites that participated in the Campylobacter "regional differences study" designed to quantify the burden of Campylobacter on retail chicken products and characterize the differences in Campylobacter between an eastern United States site (Davidson and Williamson Counties, Tennessee) and a western United States site (Alameda, Contra Costa, and San Francisco counties, California). Recently published NARMS data describe that the total number of retail meat samples tested increased to 3,533 in 2003, and overall, 6% (n =365) of 6,046 retail meat samples were contaminated with Salmonella. Salmonella was rarely recovered from ground beef and pork chop samples as compared to poultry products, with less than 2% of each commodity yielding positive cultures. Results such as these allow the tracking of pathogens in retail meat samples over time where trends can be established. These data could be used to improve standard practices related to slaughter, processing, and distribution. Complaint systems project: Tennessee EHS-Net specialist Danny Ripley, chaired this EHS-Net complaint systems working group. The working group has completed an ideal complaint system decision grid and subsequent model foodborne illness complaint form. Mr. Ripley has continued development of the computerized version of the complaint system with in-kind support from his department's Information Technology division. Ground beef grinding log study: Tennessee EHS-Net specialist Danny Ripley participated in this pilot study designed to collect preliminary information on the prevalence of in-store grinding, procedures followed and records kept. Tennessee interviewed 50 meat markets during September- November 2008. Additional studies are being considered based on these findings. Improved reporting of contributing factors in Electronic Food Outbreak Reporting System (EFORS): The previous EHS-Net PI, Dr. Tim Jones participated in the FoodNet/EHS-Net working group which looked at existing EFORS data to ascertain the completeness and reliability of "contributing factor" information associated with outbreak investigations. As the chairman of the FoodNet outbreak working group, he was instrumental in acquiring this dataset and supporting efforts to use existing data to develop methods for improving the completeness and usefulness of these data. Tennessee EHS-Net has continued to collect data associated with 100% of foodborne disease outbreaks in Tennessee and enter these data into the National Outbreak Reporting System (NORS). Tennessee submitted 100% of foodborne disease outbreaks to EFORS, obtained epidemiology and environmental program approval of 100% of reports submitted, and completed "contributing factor" questions on 100% of reported outbreaks. Tennessee Food Safety Taskforce: A Tennessee Food Safety Task Force was initiated in 2002 to focus on such issues at the state and local levels relating to various agency roles and responsibilities; capacity and resource needs; outbreak coordination and investigations; information sharing and data collection; uniform regulatory standards, communications and education; laboratory operations and coordination; issues related to adoption/implementation of the Food Drug Administration (FDA) Food Code; uniform standards for foodborne illness and outbreak reporting investigation and response; and state and local training needs for epidemiology and outbreak investigations. The Tennessee Food Safety Task Force has developed an excellent website, a table top exhibit, and a brochure for pubic distribution to facilitate communication and understanding of the roles of various food safety agencies in Tennessee that promote the taskforce. In 2008 Tennessee EHS-Net Specialist Ryan Mason secured a three year grant from FDA to support task force activities in Tennessee. We will continue with the grant process, providing updates and re-applying for the grant as needed. The Tennessee Food Safety Task Force has led efforts to enhance food safety and security by developing materials, holding tabletop exercises, and conferences. Self-Analysis for Food Excellence (SAFE) project: Mr. Ripley has continued his involvement in the "SAFE" project developed by the Metro Public Health Department's Food Protection Services. The project targets establishments with histories of poor performance on routine inspections. SAFE incorporates enhanced training and focused inspections to effectively reduce food safety violations associated with the risk factors for foodborne illness among these establishments. Critical violations have been reduced by 44% among the nearly 300 establishments enrolled in SAFE. Data suggest marked improvement in sanitation levels in participating establishments. In addition, these establishments that show dramatic improvement avoid problems associated with license revocation and other traditional interventions. Retrospective literature review, foodhandler associated outbreaks: EHS-Net staff worked with a visiting medical resident in 2006 to perform a retrospective analysis of published, restaurant- associated outbreaks, to determine the proportion in which an infected food handler was potentially implicated as a cause. The results provide important support for ongoing EHS-Net activities to better understand how to prevent food handlers from contributing to foodborne outbreaks and have been displayed as a poster at the 2009 Tennessee Food Safety Task Force meeting and at Emerging Infections Program 2009 Scientific Presentation Day. Telephone survey, foodborne/diarrheal disease knowledge, attitudes, and perceptions: EHS- Net staff assisted in design of a survey which was administered using computer-assisted telephone interviewing. Tennessee residents who participated were asked about recent illness experiences, including diagnosis, treatment, care-seeking behavior, and beliefs about causes. A manuscript with results has been submitted. Telephone survey, population education and practices on food safety: EHS-Net staff developed and launched a survey of 2,000 state residents asking about food safety education and basic food handling practices. Analysis is underway. Telephone survey regarding food recalls: EHS-Net staff participated in development of a survey of 2,000 state residents asking about knowledge, attitudes, and perceptions regarding food recalls. The survey was administered by Metro, and results were analyzed by Tennessee Department of Health staff. Results were presented at the 2009 TN Food Safety Task Force meeting and at Emerging Infections Program 2009 Scientific Presentation Day. An abstract was accepted for the 2010 Food Safety and Inspection Service (FSIS) Food Safety Education conference. Knowledge and attitudes survey regarding restaurant inspections: EHS-Net staff performed a statewide population-based telephone survey in September-December 2006, to assess knowledge, attitudes and expectations of the public regarding the restaurant inspection program. A manuscript appears in the American Journal of Preventive Medicine, 2008 Jun; 34(6):510-3. 5) Research design and methods Participation in multi-state EHS-Net studies is a high priority for TDH and Metro Nashville/Davidson County Health Department. As detailed previously, Tennessee has provided leadership to the design of several such studies and is currently involved in leading analysis and presentation of the Ill Worker Study results. We have surveyed and provided results, often in quantities nearly two fold more than required, in at least eight multi-state projects. This work involves all EHS-Net staff, two environmentalists working in two different jurisdictions that combine to cover the entire state outside of three metropolitan areas, the EHS-Net PI, and an additional epidemiologist. We will continue this level of participation, as we consider this powerful ability to generate multi-state results to be a unique and important function for EHS-Net. Tennessee's participation in EHS-Net is aimed at promoting food safety in retail food and foodservice establishments. As demonstrated above, we have invested substantial amounts of time and energy in this work for many years. Many of our efforts have focused on restaurants and include research, regulatory, and educational projects. With continued funding and inclusion in EHS-Net we are anxious to continue ongoing projects and move into less explored areas of research and intervention. EHS-Net Tennessee will continue the collaborative interagency approach by supporting two full-time environmentalists, one in the state's food safety program and one in the large metropolitan food safety program, Nashville/Davidson County Health Department. The placement in these agencies gives EHS-Net access to foodservice establishments throughout the state and to >800 groceries, markets, and convenience stores in metropolitan Davidson County. Vital channels of communication and collaboration have been strengthened by actively working together on EHS-Net projects, and food safety has been improved. These environmental specialists and the EHS-Net PI will actively contribute to the development, implementation, data collection, analysis, and presentation of multi-state food safety projects and will be active participants during steering committee and working group calls. It is exciting that EHS-Net will add grocery stores/markets as stakeholders in its work to prevent foodborne illness. In Nashville/Davidson County, Tennessee, we have an environmental health specialist in place in the agency with regulatory jurisdiction over grocery stores and can easily contribute expertise in interacting with management and working in those settings. We propose initiating EHS-Net work in these settings in Tennessee with an introductory survey effort. The EHS- Net specialist will visit a 10% random sample of the more than 230 grocery stores in this catchment area to complete a questionnaire that specifies whether the store includes a delicatessen, meat counter, butcher, meat grinding service, fresh seafood offerings, a bakery, or a salad bar. Questions regarding number and training of managers and employees, hours of operation, and local or corporate ownership/franchise will also be included. This project will require substantial effort during approximately three months. Building this grocery store database will allow us to describe the retail grocery sector in this metropolitan area and will inform discussions locally and with EHS-Net partners about further study and interventions in these settings. CIFOR Performance Indicators for Foodborne Disease Programs suggest that evaluation of food flow and contributing factors in a restaurant-associated foodborne outbreak are important to proper investigation and should be performed for each outbreak with a vehicle identified. Environmental specialists in Tennessee have gained valuable experience performing such evaluations by participating in the EHS-Net Outbreak Study and regional Epi-Ready Training. Additionally, an EHS-Net specialist, the state's foodborne outbreak coordinator, and the assistant director of Tennessee's State Public Health Laboratory (SPHL) participated in an Epi-Ready Train- the-Trainer course. EHS-Net staff will assist in training environmental and epidemiology staff statewide in the use of investigation techniques that aid outbreak investigation rather than simply complete regulatory inspection requirements. This environmentalist-epidemiologist team will plan, organize, and facilitate four regional outbreak training exercises throughout the state in 2010. It is expected that >200 nursing, environmental, epidemiology, and laboratory staff who actively participate in foodborne disease outbreaks will attend these interactive sessions and that regional coordinators will subsequently take the training to all county health departments and environmentalists in the state. Additional and ongoing training to use outbreak specific inspection techniques and a cooperative, analytic epidemiology approach by field staff is critical to identifying food vehicles. This training will emphasize evaluation of food flow and contributing factors. We will subsequently promote use of the EHS-Net Outbreak Study investigation tool by environmentalists statewide in conducting these investigation inspections. Evaluation of this effort will be completed by measuring CIFOR Performance Indicators annually. The EHS-Net specialist working in the Nashville/Davidson County catchment area has been involved since 2005 in developing and administering a remedial food safety training program for poorly performing restaurants and their management and staff. During this time 342 restaurants and 609 foodworkers have participated in what is called SAFE training that includes classroom review and onsite evaluation of each restaurant's facilities. While participating restaurants consistently demonstrate mar...